Targeting Pathways Involved in Cardiac Injury for Novel Repair Strategies

Koch PPG – Overall Program
SUMMARY
Heart Failure (HF), a syndrome that results from cardiac injury/stress, is a major world-wide health burden and
improvements in therapy are needed, which allow for novel and innovative research opportunities. This new
Program Project Grant (PPG) proposes novel concepts with specific inter-related basic research areas of cardiac
injury and repair that can truly provide translational impact. The investigators of this PPG have a mutual interest
in HF and post-cardiac injury research and are focused on identifying signaling pathways and molecular
mechanisms of HF and this includes development of novel mouse models to test various hypotheses. We are
also interested in how the failing heart can communicate to distant organs, such as the kidney, where cardiorenal
syndrome is a critical, yet understudied, clinical issue. We all are committed through our distinct, but
complementary and synergistic, research directions to uncover pathways involved in cardiac
injury/stress that can be targeted therapeutically. This represents the overall theme of our PPG application
and the overarching hypothesis is that novel therapeutic strategies can be identified based on the molecular
mechanisms we uncover in our individual projects. This supports the innovation of our P01, as improved
therapies are desperately needed for HF, cardiorenal syndrome and post-ischemic myocardial injury, since these
conditions continue to rise and lack effective therapies to reverse disease. Importantly, this PPG will address
sex differences in our models of cardiac injury and repair, which is a priority within the cardiovascular community.
Overall, we have designed this PPG to include inter-related but independent projects that will be strengthened
by existing collaborations, assets and synergy. Project 1 (Koch) examines the role of G protein-coupled receptor
kinase 5 (GRK5) in the pathophysiology of the heart with a focus on the non-canonical actions of this kinase in
the nucleus of myocytes. Project 2 (Kishore) will examine how gender influences the functionality of stem cell
properties for ischemic myocardial repair, particularly epigenetic basis of gender differences in stem cell function.
Project 3 (Tilley) is focused on leukocyte-mediated regulation of renal fibrosis, dysfunction and progression of
cardiorenal syndrome during the development of HF. Project 4 (Elrod) focuses on mitochondrial calcium
regulation in heart failure and how components of the mitochondrial calcium uniporter are involved. Studies in
these Projects range from cellular to whole heart to inter-organ regulation in order to test our guiding hypothesis
and theme. All four Projects will be supported by one administrative and two scientific Cores that offer murine
surgical and physiological support (Core B-Gao) and myocyte and viral vector support (Core C- Rajan). A PPG
is an appropriate mechanism for these collaborative studies to uncover novel data concerning cardiac injury and
repair and working together will significantly accelerate discovery and interaction to foster scientific inquiries
beyond those outlined here.

Public health relevance
Koch PPG – Overall Program NARRATIVE Heart Failure remains a major health problem world-wide and there are gaps in research that are needed to be filled in order to develop innovative treatments to minimize cardiac injury and repair the failing heart. Understanding molecular mechanisms, and gender differences involved in cardiac injury and repair is imperative in order to begin to develop these novel therapies. This includes how the injured heart communicates to distant organs to create co-dependent pathologies such as cardiorenal syndrome and all projects within this Program Project have goals to move towards translating discoveries into development of novel therapies.